Toward Validating a Measure of Tonic and Phasic Irritability in Community and Clinical Samples

Project Summary/Abstract
Irritability is one of the most common mental health problems in children and adolescents. Moreover, it is one
of the strongest predictors of later psychopathology and functional impairment in adulthood. Irritability can
manifest in a variety of ways, which has recently led some investigators to conceptualize it as consisting of two
components: tonic irritability, defined as persistently angry or grumpy mood; and phasic irritability, defined as
short-lived temper outbursts. Though this distinction has been raised conceptually, research examining
whether tonic/phasic irritability are empirically separable and differ in their clinical correlates, underlying
mechanisms, longitudinal course, and treatment response is limited. A significant obstacle for empirical work in
this area has been that no psychometrically validated measure that differentiates between tonic/phasic
irritability is currently available for research or clinical use. Long-term objectives. I propose to develop and
evaluate the first multi-informant measure of tonic/phasic irritability for school-age children and adolescents.
This measure will fill an urgent gap in the literature by providing a psychometrically-sound, multi-informant
instrument that will advance research on the etiopathogenesis of tonic/phasic irritability and help develop and
evaluate targeted approaches to prevention and treatment. Design. I developed the tonic/phasic scale by 1)
conducting a comprehensive literature search of existing instruments that cover related constructs, 2) utilizing
experts in developmental psychopathology to revise and refine the item pool, and 3) conducting cognitive
interviews with parents of children and adolescents using a combined think-aloud and debriefing methodology.
The proposed project will collect data from five samples including three convenience community samples (a
total of ~800 parents of 6–17-year-old children and ~800 unrelated 13–17-year-old youth) collected through
Qualtrics XM panels, allowing for an iterative scale development process; a longitudinal dataset (~215 parents
of 6-year-olds enriched for irritability) with a wider set of validating measures; and a clinical sample (~150
parents and their ~150 10–17-year-old children in outpatient psychology and psychiatry clinics) to evaluate the
generalizability of the measure to a more severely impaired population. In each sample, participants will
complete a brief survey assessing irritability and emotional and behavioral symptoms. Aims/Methods. The
aims of this project are five-fold: 1) develop and refine a novel multi-informant scale for assessing youth
tonic/phasic irritability using classical psychometric and item-response theory (IRT) analyses; 2) evaluate
convergent and discriminant validity by examining concurrent relationships of tonic/phasic irritability with
existing measures of irritability, parental psychopathology, parenting style, child temperament, and child
psychopathology; 3) assess predictive validity by modeling relationships between tonic/phasic irritability and
later measures of youth psychological problems; 4) evaluate measurement invariance for informant, age,
biological sex, and race/ethnicity; and 5) develop a shortened version of the rating scale using IRT.

Public health relevance
Project Narrative Because tonic and phasic irritability in childhood and adolescence predict somewhat different mental disorders and poorer functional outcomes across the lifespan, developing measures specifically designed to assess both the tonic and phasic components of irritability is paramount to continued empirical work in understanding, preventing, and treating youth irritability. By developing and validating a multi-informant rating scale for tonic and phasic irritability, the study will advance the goal of generating a reliable and robust assessment tool to predict illness onset and course in youth. Findings from the study will lay the groundwork for optimizing prediction of risk for specific forms of psychopathology, potentially aiding the identification of those most in need of services and indicating which interventions might be most effective and facilitate assessment of more specific treatment targets.